Glutamate receptors and human neurological disease

Abstract/Summary of my R35 Program
This R35 Research Program proposal will use electrophysiological, molecular, and structural approaches to
probe multiple aspects of excitatory synaptic function that are relevant for neurological disease. We will focus on
the elucidation and modulation of the functional properties of postsynaptic glutamate receptors. We will take
advantage of coincident advances in cryoEM, genetics, robotics, and receptor biology to address questions that
were previously inaccessible. Four approaches will address critical gaps in our understanding of synaptic
function and provide therapeutically-relevant insight into neurological disease.
First, we will explore the functional and clinical implications of regional intolerance for variation in the healthy
population as well as de novo disease-associated glutamate receptor mutations, most commonly found in
GRIN1, GRIN2A, GRIN2B, GRIN2D genes that are among the least tolerant in the genome. We will establish
the relationship in healthy individuals between allelic frequency and functional changes, which is necessary in
order to understand the role of SNPs in these genes as disease risk factors. Evaluation of these rare variants
will also provide opportunities for precision medicine, and advance our understanding of receptor function.
Second, we will develop novel compounds for proof-of-concept studies to identify new therapeutic strategies
for neurological disorders. We will synthesize subunit-selective modulators of agonist potency and channel open
probability to assess the roles of understudied NMDA receptor subunits (e.g. GluN2C, GluN2D) in circuits in
cortex, thalamus, and striatum. We will determine the site and mechanism of action of modulators of NMDA
receptors, and use medicinal chemistry to improve brain penetration, potency, and solubility in collaboration with
Dennis Liotta in Chemistry at Emory. We will use the pharmacological tools that we develop to gain insight into
the treatment of epilepsy, stroke, Parkinson’s disease, and Alzheimer’s disease.
Third, we explore biased modulators of NMDA receptors by developing the SAR of two classes of compounds
that alter ion channel selectivity. These compounds represent the first example whereby a pharmacological
agent can alter channel permeation properties, demonstrating that modulators can tune distinct functions of the
NMDA receptor. These compounds hold enormous potential as neuroprotectants that diminish cation flux without
side effects associated with receptor blockade, which we will evaluate in vivo in models of ischemia.
Fourth, we will combine information obtained through genetic analysis of regional intolerance, mechanism of
allosteric modulation, and new advances in structural biology to advance our understanding of the mechanisms
that convert glutamate binding to channel opening. These experiments will focus on the shared regions of the
protein that control channel opening, which are the key sites of action of our allosteric modulators and common
sites for disease-associated human mutations. We will collaboratively perform cryoEM and crystallographic
studies to determine the binding site for modulators, as well as key features of channel structure and function.

Public health relevance
Narrative Glutamate-activated NMDA receptors mediate a Ca2+-permeable component of excitatory synaptic transmission in the brain that is involved in learning, memory, and development. NMDA receptors have been implicated in a wide range of neurological conditions, and there is intense interest in the development of allosteric modulators as new therapeutic treatments for neurological disease. This research program is designed to address all key aspects of glutamate receptor signaling, including the structural underpinnings of function, genetic variation as it relates to rare disease and risk factors, identification of therapeutically-relevant molecules that can be used as probes to develop novel treatment strategies, and the fundamental process of synaptic transmission.